IMPLEMENTATION OF A CRYOGENIC RECEIVER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This subproject (phase 3) is intended to implement a cryogenic receiver. For this receiver system we require a cryogenic low-noise amplifiers (LNA) for Ku and Ka frequency bands from a company (e.g. Spacek Labs, Inc.) with the reputation for building such devices for Radio Astronomy and space. The LNA input will be protected with a custom-built cryogenic receiver protector switch. The cryogenic LNA, switches, and probe-head will be mounted on a carrier plate, housed by the developmental cryostat. Components external to the cryostat include Ka-band transceiver, electronics presumably comprised of DSP-controlled ACERT BN2 pulse programmer, and the AP240-based data acquisition system.